Developing mathematical model driven optimized recurrent glioblastoma therapies

Abstract
High-grade gliomas, including GBM, are the most common primary brain tumors in adults. GBM treatment is
not curative, and recurrent high-grade glioma (rHGG) remains fatal, despite aggressive therapy. Part of the
challenge in treating glioma is its localization within the naturally immunosuppressive central nervous system.
Hypofractionated stereotactic radiotherapy (HFSRT) combined with immunotherapy has shown promising
antitumor activity in both preclinical and clinical studies in rHGG. Radiation induces an immunogenic cancer
cell death and promotes the presentation of tumor-derived antigens to antitumor T cells, and acts
synergistically with immunotherapy to enhance the immune response against tumor cells. Treatment response
depends on a myriad of factors, including patient, tumor, and treatment parameters. Thus, how to best
combine radiation with chemotherapy or immunotherapeutics remains unknown. Current protocols of
combining radiation with different therapies are applied without considering evolutionary dynamics, and every
patient's tumor develops resistance and eventually progresses. We hypothesize that evolutionary principle-
guided therapies must be explored to pro-actively counteract the development of resistance. Mathematical
modeling may provide the necessary tools to decipher the complex evolutionary dynamics during rHGG
therapy. Trained and tested mathematical and computational algorithms can simulate a variety of treatment
protocols in all possible combinations. Our innovative approach and goals are to integrate mathematical
modeling to learn from past clinical studies to design a prospective clinical trial in rHGG. Using mathematical
and computational algorithms to exhaustively explore different treatment protocols holds the key to improved,
clinically-testable protocols, and ultimately improved rHGG outcomes. This interdisciplinary team science
approach combines our expertise in neuro-oncology and radiation oncology with mathematical oncology and
statistics. Moffitt Cancer Center has a rich culture of interdisciplinary research across conventional department
barriers, as evidenced by a strong history of translating mathematical and computational concepts into
experimental biology as well as clinical trial and practice. Here we build on robust preliminary data to harness
our expertise and explore evolutionary principles-guided therapies for the first time in rHGG.

Public health relevance
Narrative Treatment of high-grade gliomas such as glioblastoma (GBM) is rarely curative, and recurrent high-grade glioma (rHGG) patients face a dismal prognosis with median overall survival rates of less than one year. Here, we hypothesize that improving rHGG responses and outcomes requires novel treatment protocols that harness evolutionary principles to maximally delay time to progression. This proposal's overall goal is to combine our mathematical and clinical expertise to improve response rates and outcomes for rHGG patients.